SYNAPTIC VESICLE PROTEIN 2 AND NEUROSECRETION

THIS IS A SHANNON AWARD PROVIDING PARTIAL SUPPORT FOR THE RESEARCH PROJECTS THAT FALL SHORT OF THE ASSIGNED INSTITUTE'S FUNDING RANGE BUT ARE IN THE MARGIN OF EXCELLENCE. THE SHANNON AWARD IS INTENDED TO PROVIDE SUPPORT TO TEST THE FEASIBILITY OF THE APPROACH; DEVELOP FURTHER TESTS AND REFINE RESEARCH TECHNIQUES; PERFORM SECONDARY ANALYSIS OR AVAILABLE DATA SETS; OR CONDUCT DISCRETE PROJECTS THAT CAN DEMONSTRATE THE PI'S RESEARCH CAPABILITIES OR LEND ADDITIONAL WEIGHT TO AN ALREADY MERITORIOUS APPLICATION. THE ABSTRACT BELOW IS TAKEN FROM THE ORIGINAL DOCUMENT SUBMITTED BY THE PRINCIPAL INVESTIGATOR. DESCRIPTION: The identification of the molecular events producing and regulating neurotransmitter release is a central goal of neurobiology. An understanding of this phenomenon is crucial to several applied fields of neuroscience, including the study of learning and memory and the etiology of nervous system pathologies. The release of neurotransmitters is the summation of many events, each of which is a potential site of regulation. The larger goal of Dr. Bajjalieh's laboratory is to identify the proteins that mediate neurosecretion, their activity, and how their action is regulated. The work proposed here addresses the function of Synaptic Vesicle Protein 2 (SV2), a component of all synaptic vesicles. Sequence analyses indicate that SV2 belongs to a family of transporter proteins. Based on this similarity and analyses of SV2 isoform expression, it has been hypothesized that SV2 serves as a transporter of a common vesicle constituent, as a plasma membrane sugar transporter, or as a fusion pore. Early attempts to identify the action of SV2 by antibody neutralization and expression in non-neuronal cells have been inconclusive. The activity of SV2 remains unknown. The following studies are designed to identify proteins and post-translational modifications required for SV2 activity and to test hypotheses of its function. These studies will ask: 1) What proteins interact with SV2? The identification of associated proteins is often a first step in determining a protein's function. These studies will provide information on SV2's action by identifying co-factors and regulators. 2) What kinases and phosphatases act on SV2? Preliminary experiments indicate that SV2 is phosphorylated in nerve terminals and that its phosphorylation may be regulated by synaptic activity. These studies will provide information on the regulation of SV2 that may be crucial to a direct demonstration of its activity. 3) How does depletion of SV2 expression affect secretion in cultured neuroendocrine cells? Stable cell lines which express low levels of SV2 will be generated. These cell lines will be used to test several hypotheses of SV2 function.